Research Training in Women's Health and Intersectionality Using Data Science and Health Information Technology (WISDOM)

Researchers have challenged the notion of women’s health universality, an idea that essentializes women’s
health care needs regardless of their race/ethnicity, cultural background, age, social class, geographical
locations, and sexual identity (social determinants of health). These researchers subsequently assert the need
to consider the intersectionality of these multiple forms of discrimination in women’s health research. Intersecting
forms of social disadvantage and marginalization are frequently associated with adverse health outcomes.
Nurses, who have long been at the forefront of women’s health initiatives, are in an ideal position to participate
in and lead teams of researchers, health care providers, policymakers, and the lay public in a contemporary
commitment to strengthen women’s health. However, lack of significant training in data science (DS) and
emerging health information technologies (HIT) reduces the effectiveness of nursing scientists in women’s health
research. The use of DS and HIT can improve research effectiveness in reducing health disparities among
disadvantaged groups of women by providing various strategies that were not possible without these
methodologies (e.g., increasing access to hidden populations, improving the precision of measurements).
The purpose of this T32 program is to prepare nurse scientists who have knowledge and skills to employ DS
and/or HIT in order to improve women’s health while considering the intersectionality of multiple social
determinants of health. This is in agreement with the overarching goals of Healthy People 2030, the NINR
strategic plan (especially research lenses on health disparities and social determinants of health), the Trans-NIH
Strategic Plan for Women’s Health Research, the IOM Report on Women’s Health Research, and the American
Academy of Nursing’s Women’s Health Research Agenda. This training will build on the strengths of the Emory
University Nell Hodgson Woodruff School of Nursing’s currently funded research studies, faculty expertise, and
supporting infrastructure. It will address women’s health issues with a conceptual focus on intersectionality
among social determinants of health. Trainees will also develop knowledge and skills in interdisciplinary research
methods related to women’s health, understand and apply DS and/or HIT, and/or develop and test interventions
using DS and/or HIT in women’s health. The program comprises: 1) specific courses related to women’s health,
DS, and HIT; 2) electives to individualize training, develop an area of specialization, and facilitate trainees in
interdisciplinary courses; 3) biweekly T32 seminars to foster trainees’ integration of course content with other
program experiences; 4) 15 hours a week of work on faculty research over several semesters; 5) at least one
semester of individualized research practicum with center internships; and 6) participation in an interdisciplinary
center on campus that relates to the trainee’s research area. Fifteen nurse scientists will be trained over 5 years.
The program will engage 17 mentors and 6 Interdisciplinary co-mentors. Over 10 research
centers/institutes/departments have agreed to collaborate, making this a fully interdisciplinary training program.

Public health relevance
Project Narrative Social disadvantage and marginalization due to intersectionality of multiple social determinants of health are frequently associated with women’s adverse health outcomes. The use of data science and health information technology will improve research effectiveness in reducing health disparities among disadvantaged groups of women by providing various strategies that were not possible without these methodologies (e.g., increasing access to hidden populations, improving the precision of measurements). The proposed T32 program trains pre- doctoral and post-doctoral nursing scientists within interdisciplinary teams to have knowledge and skills to employ data science and/or health information technology in order to improve women’s health while considering the intersectionality of multiple social determinants of health.